Polysomes & Subunits: Structure-Function Relationships

The long-term goal of this grant proposal is to understand at an atomic level how the ribosome functions during protein synthesis. We will take a multidisciplinary approach utilizing genetic, biochemical and structural methods to study the bacterial ribosome. Our first aim is to examine ribosome structural dynamics during decoding of mRNA and its inhibition by antibiotics. We will use X-ray crystallography to obtain high-resolution structures of mutant Thermus thermophilus 30S subunits that reveal new conformational states. We will examine the effects of the mutations on the accuracy and kinetics of decoding. Our second aim is to probe a pathway by which codon recognition is signaled via ribosomal protein S12 and aminoacyl-tRNA to EF-Tu to activate GTP hydrolysis, a key step in the tRNA selection process. These experiments are designed to provide fundamental insights into ribosome structure and function, including new conformational states of the ribosome, to aid in understanding the decoding process. The ability to solve structures of ribosomes with antibiotic-resistance mutations will aid in understanding the mechanisms of antibiotic action and resistance, and has particular clinical relevance for the rational design of drugs to fight resistant microbial pathogens.

Public health relevance
: The goal of this project is to further our understanding of the molecular mechanisms of protein synthesis at the atomic level, using the methods of structural biology, genetics and biochemistry. Protein synthesis in bacteria is the target of over half of all antibiotics, and modifications and mutations in components involved of this process can lead to antibiotic resistance, one of the most pressing medical problems of our time. Deciphering the molecular basis for antibiotic resistance will provide important information needed for the rational design of novel antimicrobial agents effective against antibiotic resistant microorganisms. A more comprehensive examination of the structural basis for protein synthesis will also provide important insights into one of the most fundamental processes found in all forms of life.